Stanford Cancer Institute

Project Summary/Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
24-041.
The Stanford Cancer Institute’s (SCI) mission is to leverage the broad and unique strengths of Stanford
University in basic science, bioengineering, population science, biostatistics, technology development, clinical
research, clinical care, and translation to (1) improve the diagnosis, treatment, and outcomes of cancer patients;
(2) understand cancer etiologies among diverse populations; and (3) decrease cancer incidence in the SCI
catchment area and beyond. SCI is committed to improving long-term outcomes by ensuring that cancer
survivors have access to guideline concordant survivorship care, including timely referrals to supportive services
and preventative care. This proposal is designed to evaluate the alignment of survivorship care delivery within
clinical care programs at the Comprehensive Cancer Center in Palo Alto and network sites, with the National
Standards for Cancer Survivorship Care.
In partnership with operational leaders and project managers at Stanford Healthcare, we will use a mixed
methods approach to leverage data that exist in the electronic medical record, cancer center registry, institutional
policies, and implementation projects; and supplement this by adding surveys and in-depth interviews with key
informants and stakeholders. Integrated data analysis will inform a comprehensive report of the effectiveness
and reach of Stanford’s Cancer Survivorship Program, alignment with the National Standards for Cancer
Survivorship Care, and gaps and barriers to care delivery. Key findings will provide data to support the allocation
of resources, customization of workflows and training of staff and healthcare professionals. Activities proposed
in this research are highly aligned with the SCI’s commitment to understand and address gaps in survivorship
care and will lead to research initiatives designed to test new models of care and interventions to improve
physical, emotional, and mental health. Ultimately, this work aims to harmonize best practices across the
Stanford network in line with national survivorship care standards, improve the quality of survivorship care, and
thus enhance the long-term outcomes and well-being of all cancer survivors.

Public health relevance
Project Narrative The long term-goal of the proposed study is to develop effective strategies to ensure that cancer survivors have access to guideline concordant care and timely referrals to supportive services at Stanford Medicine. The project will evaluate Stanford’s alignment with recently issued National Standards for Cancer Survivorship Care, identify gaps and barriers to effective care delivery, and provide data and insights to inform survivorship care implementation, resource allocation, and training of professionals to deliver quality survivorship care.